The impact of inflammation on HSPC composition and disease progression in chronic myelomonocytic leukemia

Project Summary:
Chronic Myelomonocytic Leukemia (CMML) is an aggressive myeloid neoplasm hallmarked by bone
marrow dysplasia, cytopenias, peripheral monocytosis, and a propensity for Acute Myeloid Leukemia
(AML) transformation. Although uniformly fatal, CMML initially present in a clinically asymptomatic state
and is monitored, without treatment, for a period of weeks to months. In all patients, CMML invariably
progresses to either a more symptomatic version of disease or undergoes AML transformation. It is this
lethal transformation that is responsible for CMML's dismal prognosis and median survival of only 34
months. Importantly, the molecular determinants of progression are poorly understood. CMML disease
progression and AML transformation have been historically associated with changes in genetic
architecture termed “clonal evolution.” However, a large subset of patients harbor the same somatic
mutations and variant allele frequency at the time of progression to that at diagnosis. Our laboratory has
discovered a non-clonal evolutionary adaptation whereby leukemic hematopoietic stem cells differentiate
to inflammatory GMPs leading to increased fitness in the context of inflammation while maintaining the
same repertoire of somatic mutations. Further, this adaptation was associated with adverse outcomes in
a retrospective cohort of CMML patients. Last, preclinical inflammatory models of CMML were able to
recapitulate this evolutionary adaptation in our preliminary data. Therefore, we hypothesize that
inflammatory insults induce the differentiation of leukemic GMPs that are tightly associated with disease
progression. This hypothesis will be tested in the following specific aims: (1) Establish the first prospective
longitudinal cohort study in CMML. It is very difficult to capture all inflammatory insults via retrospective
clinical analysis. To address this, this aim will assemble the first multi-institution prospective longitudinal
cohort study of CMML specifically designed to determine whether inflammatory insults are associated with
disease progression. Second, we will utilize samples from this study to validate bulk gene expression
signatures and a flow-based assay to identify those CMML cases with and inflammatory GMP biased state.
Last, we will leverage retrospective cohorts of treated CMML to determine the impact of existing therapy on
this GMP biased state. (2) Determine whether the inflammatory GMP biased state is an evolutionary
adaptation that can be therapeutically exploited. In this aim, we will use both genetically engineered and
patient derived models of CMML to establish the clonal origin of inflammatory GMP, there self-renewing
capacity, and the impact of early therapy on this population of cells.

Public health relevance
Project Narrative: The conventional clinical management strategy for patients with chronic myelomonocytic leukemia (CMML) is to initiate therapy at the time of disease progression and clonal evolution. In this project, we will determine whether inflammatory insults can drive a specific evolutionary adaption known as the `mono-biased' state and disease progression. Importantly, we will determine if this inflammation dependent effect can be mitigated by existing therapeutics and cytokine inhibitors leading to a paradigm shift in CMML management whereby these therapies can be deployed in a clinically asymptomatic state to prevent disease progression.